Consortium for Advancing Management and Prevention of Cancer in People with HIV

The mission of the AIDS Malignancy Consortium (AMC) is to investigate through clinical trials new
treatment and prevention interventions and study the pathobiology of malignancies and their precursors in people
living with human immunodeficiency virus (PLWH) in the United States (U.S.) and internationally. The vision of
AMC is to reduce incidence, morbidity, and mortality of cancers occurring in PLWH.
Since the AMC was established in 1995 (and as of 11/18/24), it has initiated over 97 interventional clinical
trials including 10,787 subjects, resulting in 319 publications and 197 abstracts/presentations, and generated
evidence that has transformed practice guidelines in the U.S. and low-middle income countries (LMIC) that have
a high HIV burden. AMC has established a network of 39 clinical trial sites (including 29 in the U.S, 6 in sub-
Saharan Africa, and 4 in Latin America) that are uniquely qualified to carry out its mission, created a network of
translational scientists and their research laboratories that support AMC clinical trials, and developed a Career
Enhancement Program (CEP) that has fostered a new generation of AMC leaders. AMC has also actively
engaged PLWH and cancer survivors in its scientific planning and community outreach in order to better identify
the needs of the community, both within the U.S. and globally, as evidenced by the establishment of a Global
Community Advisory Board (CGAB) and inclusion of advocates in strategic and protocol planning.
AMC has functioned as a single cooperative group since 2005 under the supervision of the Office of HIV-
AIDS Malignancies (OHAM) within the Office of the Director of the National Cancer Institute (NCI). This
centralized leadership and accountability has helped create a more cohesive structure and uniform approach to
group operations and strategic planning. Although AMC focused initially on small pilot, phase I and II trials, the
scope of its activities has broadened to include 3 practice-changing randomized phase III trials, including 2 in
KS in collaboration with the AIDS Clinical Trials Group (ACTG), and the landmark ANCHOR trial in the U.S.
which demonstrated that treatment of anal high-grade squamous intraepithelial neoplasia (HSIL) reduced the
incidence of invasive anal cancer, having a profound impact on clinical practice and future research priorities
regarding how to most effectively screen for and treat high-grade anal HSIL.
Despite challenges posed by the Covid-19 pandemic during years 14-18 of the current funding period,
AMC launched a new generation of trials that built upon its prior work, increased overall accrual, began new
initiatives in cancer control, prevention, and survivorship, expanded its collaborations with other NCI-funded
networks, expanded its laboratory network and biorepository program, and expanded its career enhancement
program. AMC will continue to developing hypothesis-driven pilot, phase I, I-II, and III trials designed to address
its mission and vision.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Cancer has been recognized as occurring more commonly in people living with human immunodeficiency virus infection (PLWH), and remains a leading cause of morbidity and mortality despite improvements in antiretroviral therapy. The spectrum of these cancers in PLWH is diverse, complex, and challenging to prevent and treat. AMC remains the only organization worldwide solely dedicated to the study, treatment and prevention of cancer in PLWH.